ELECTRONIC PROPERTIES OF FLEXIBLE MOLECULES UNDER LASER EXCITATION &HIGH PRESS

The kinetics of fluorescence and phosphorescence of several twisted intramolecular change transfer (TICT) molecules (DMABN-dimethylaminoloeusonitnile; DMABA P dimethylquominskeusaldehyde, MK) dispersed in polimeric matrices (PMMA-poly(methyle methacrylate), PVCL-poly (vinyl chloride), PVP-poly (vinyl pinjdine) etc.) is studied under high hydrostatic pressure (up to 100 klbars). Under continous irradiation conditions the above molecules exhibit a new emission band which is primarily phosphorescence in origins from the light-induced fluorphores The population and lifetime of the new molecular states depend strongly on the intensity of the excitation light and the applied pressure. The excited state reaction between TICT molecules and polymer is consider to be responsible for creation of the meta stabele photoproduct.